Large-scale profiling of microbial and metabolic interactions between C. difficile and gut microbiota using ultrahigh-throughput droplet microfluidics

PROJECT SUMMARY/ABSTRACT
Clostridium difficile (C. difficile) is a major antibiotic resistant intestinal pathogen that is a leading cause of
antibiotic associated diarrhea and colitis which, in severe cases, can lead to death. Treatment with antibiotics
frequently leads to recurrence of the infection, which is then treated with fecal microbiota transplantation (FMT).
In this case, a fecal sample from a healthy donor is transplanted into a patient with C. difficile infection, which
has been shown to prevent recurrence of infections. Notably, FMT can lead to negative health outcomes
including death due to the potential transmission of pathogens and uncharacterized factors in the samples. The
observed efficacy of FMT suggests that commensal gut bacteria play a critical role in suppressing infection
caused by C. difficile. Previous studies have elucidated specific molecular mechanisms that can influence C.
difficile colonization including exploitation of key nutrients available in the inflamed gut and secondary bile acids.
We postulate that there are diverse classes of ecological and molecular mechanisms mediating protection from
C. difficile depending on the ecological and environmental context. Indeed, treatments of C. difficile infection
based on defined microbiota have not proven successful. To elucidate the diverse classes of mechanisms, we
propose to develop a droplet microfluidic workflow to construct millions of synthetic human gut communities,
screen these consortia based on the abundance of C. difficile and determine species composition of the sorted
“hits.” Combining this method with exo-metabolomics and machine learning techniques, we will infer microbial
interactions and metabolite effectors impacting C. difficile growth. A detailed understanding of the diverse
community types and metabolic properties that suppress C. difficile growth will be a major advance towards
designing safe and effective treatments for this major intestinal pathogen.

Public health relevance
PROJECT NARRATIVE The antibiotic resistant intestinal pathogen Clostrodiodes difficile (C. difficile) is the leading cause of hospital- acquired infections in the US and there are a rising number of community-acquired cases with substantial associated morbidity and mortality. To understand the complex ecological and environmental factors that impact the growth of C. difficile in the gut microbiome, we aim to develop and apply a novel method for quantifying C. difficile growth in millions of synthetic human gut microbiome communities. Equipped with this data, we will use machine learning techniques to decipher the metabolite features and microbe-microbe interactions driving C. difficile growth.